Anti-viral Mechanisms of Defensins

Project Summary
The innate immune response is a critical component of host defense against infection. Alpha-defensins, one
family of antimicrobial peptides, are an evolutionarily conserved class of innate immune effectors with well-
described anti-bacterial activity; however, their role in viral immunity is less well understood. The potent
neutralization of diverse viruses by alpha-defensins has been described in vitro and in cell culture. By focusing
on human adenovirus and papillomavirus, we have identified a common mechanism whereby alpha-defensins
bind to the viral capsid and alter uncoating during cell entry to block infection. Recently, we have found that
viruses transmitted by the oral/fecal route (e.g., rotavirus and enteric adenovirus) are selectively resistant to
the antiviral activity of alpha-defensins from their host species while remaining sensitive to non-host alpha-
defensins. In some cases, the host alpha-defensins even increase or enhance the infection of these viruses,
leading us to hypothesize that enteric viruses have evolved to either evade or hijack these host defense
peptides to increase infection and transmission. To test this hypothesis, we will study the enhancement and
neutralization of rotavirus by host and non-host alpha-defensins. Rotaviruses are important human pathogens
and a deeper understanding of host factors that dictate their tropism is important for understanding
transmission. These studies will combine biochemical and genetic approaches to identify alpha-defensin
binding determinants on the viral capsids and to identify alpha-defensin properties that differentiate neutralizing
and enhancing activities. We will also identify the mechanisms of rotavirus neutralization and enhancement.
Finally, we will determine whether or not these mechanisms alter viral infection in vivo.
To determine whether the antiviral mechanism that we have uncovered in our studies of adenovirus and HPV
is general, we will also dissect the mechanism of parvovirus inhibition. Parvoviruses, particularly adeno-
associated virus, are important viral vectors. In addition, there are well known (e.g., B19) and emerging (e.g.,
bocavirus) parvoviruses that are important human pathogens. These studies will be facilitated by high
resolution structural studies of clinically relevant viral vectors. From these comparative studies of two
disparate families of non-enveloped viruses in combination with our prior insights from human adenovirus and
papillomavirus, we will gain a deeper understanding of the function of a critical component of the immune
system that may be a common factor in the pathogenesis of many viruses. These studies may also aid in the
development of alpha-defensins as therapeutics and inform vaccine design.

Public health relevance
Project Narrative We will determine how a part of the immune system blocks virus infection. These studies may uncover new ways to prevent disease and may guide the design of antiviral drugs and vaccines.